Pittsburgh Older Americans Independence Center

The overall goals of the Pittsburgh Claude D. Pepper Older American Independence Center (OAIC), funded since 2004, are to address the critical need to improve mobility, balance, and falls risk. We will continue to achieve these goals both through improved understanding of their causes and through development of preventive and therapeutic interventions. New for this renewal we will extend our work and partnerships into new and high potential areas and bring several innovations to our activities and Cores.

Public health relevance
Mobility and balance disorders are common among the aged and contribute to reduced physical activity, falls, injuries, disability, loss of independence and health care utilization. Our multidisciplinary group of collaborative investigators are dedicated to fostering optimal mobility and balance among older Americans, both through improved understanding of their causes and by developing preventive and therapeutic interventions to reduce falls and maintain independence.